TRPC6 inhibition therapy to rescue cardiac muscle dysfunction in muscular dystrophy

This proposal tests the efficacy and mechanisms by which a recently developed, bioavailable, selective
small-molecule inhibitor of Transient Receptor Potential Canonical 6 (TRPC6) ameliorates cardiac and
skeletal myopathy in Duchenne muscular dystrophy (DMD). This research fulfills the candidate’s
long-term goals of advancing novel therapies for dystrophic cardiomyopathy and applying
mechanosensitive signaling assays in mice and engineered heart tissues (EHT) to study disease. DMD
results from a loss of dystrophin, inducing profound progressive muscle weakness, spinal deformities,
fibrosis, heart failure, and early mortality. TRPC6 is a mechanosensitive, non-voltage gated cation
channel expressed in muscle cells that is hyper-activated in DMD, mediating excessive mechanical
stress-induced force/Ca2+ responses, arrhythmias, cardiac dysfunction, and muscle fibrosis. During the
candidate’s postdoctoral training, he led projects assessing the impact of blocking TRPC6 genetically and
pharmacologically in models of cardiac fibrosis. Preliminary data in DMD show genetic or pharmacological
TRPC6 inhibition prolongs lifespan in severe DMD models by 2-3 fold, ameliorating fibrosis and
associated pathology, and improving heart and skeletal muscle function. The candidate first reported on
the TRPC6 drug inhibitor (BI 749327) in 2019, and its clinical derivatives are now in human trials for lung
and renal disease. In this proposal, the candidate addresses key questions whose answers will
importantly inform future DMD translational efforts, and organized into three aims. Aim 1 tests the efficacy
of chronic TRPC6 inhibition by BI 749327 to prevent and reverse DMD skeletal and cardiac muscle
dysfunction, histopathology, and TRPC6-NFAT, pro-fibrotic and inflammatory signaling. Cell-type
expression is analyzed by single-cell RNAseq to identify how subpopulations of cardiac cells that express
TRPC6 (fibroblasts, vascular, and myocytes) are impacted by the treatment. Aim 2 tests the capacity of
chronic TRPC6 suppression to restore mechanical activation-induced defects in force and calcium in
isolated DMD mouse cardiomyocytes, and to obviate effects of membrane sealants and other
mechanosensitive-activated pathways. I will further test the role of TRPC6 pathobiology in a novel human
DMD EHT model of mechanosensitive activation using the same mechanical stimuli as in mouse
cardiomyocytes. Aim 3 tests the efficacy of micro-dystrophin (ȝDys) gene therapy to treat TRPC6
pathobiology in the recently developed D2 mdx DMD mouse model or the combination of ȝDys with BI

Public health relevance
This project identified a potent and clinically-relevant target, Transient Receptor Potential – Canonical 6 (TRPC6), that is hyperactivated in Duchenne muscular dystrophy (DMD) and contributes to heart disease. The proposed research will test 1) the only known TRPC6-inhibiting drug in three mouse models of DMD and 2) newly-developed engineered heart tissue platform that can simultaneously assess mechanical stress responses in human engineered heart tissue from Duchenne muscular dystrophy stem cell lines